USC Neurosurgery Research and Education Training Program

PROJECT SUMMARY
Receipt of individual NIH career development awards has been instrumental to the professional trajectories of
physician-scientists. However, submitting competitive applications for these awards is difficult without formal
mentorship, defined expectations, protected time, and coordinated curricula. The USC R25 Neurosurgery
Research Education Program provides the resources, mentorship, and support required to address many of
these challenges. The R25 program has advanced a culture of academic research and development of
clinician-scientists that has directly benefited the residents and junior faculty members within the USC
Department of Neurosurgery. The proposed renewal application seeks to build upon the early successes from
the initial funding cycle. This competitive renewal application leverages a similar structure to the first five years
of the program but incorporates changes/ improvements based on learning and feedback. Mentors are
clinicians and scientists with federal funding and prior track records notable for successful mentorship. Thirty-
five faculty members from seventeen different academic departments across the university are included as
mentors and advisors. A multi-tiered mentorship system affords each R25 trainee a research supervisor for
his/her direct investigative study, guidance from a Neurosurgery Research Mentorship Committee and career
development support from a team of clinician-scientists within the candidate’s chosen neurosurgery/
neuroscience subspecialty. A Transition to Academic Faculty Committee provides sustained guidance and
oversight to R25 graduates during their final years of residency training and initial junior faculty appointments.
The USC Neurosurgery residency program has been restructured to incorporate a dedicated R25 research
track that differs from the traditional clinical pathway. An innovative Senior/ Junior mentorship program will
allow R25 trainees to receive formal guidance from early career investigators in addition to experienced
scientists/ mentors. Dedicated discussions and instruction focusing on ethical and successful scientific practice
have been incorporated into the program. The over-arching aim of the proposal is to develop neurosurgeon-
scientists capable of securing NIH K-, and ultimately R-, series funding to support independent research.

Public health relevance
PROJECT NARRATIVE There is a need for well-trained neurosurgeons to perform basic science, translational, and clinical research focused on understanding and treating neurological diseases. This renewal application aims to support the development/ education of neurosurgical residents who wish to pursue careers as clinician-scientists. The research training and mentorship will afford trainees the foundation to become independent investigators who are equipped to understand and treat pathologies of the brain and spinal cord.